Accurate and rapid assessment of sarcopenia in older adults through electrical impedance myography - Development of Regulatory Plans Supplement

PROJECT SUMMARY
This administrative supplement will fund development of regulatory plans in support of commercialization of
products and technology developed by parent grant R44AG074840-01A. The parent grant is demonstrating
and validating Electrical Impedance Myography (EIM) as a fast, painless, inexpensive, non-intrusive,
accurate method for the assessment of lower extremity muscle condition in older adults. In the parent grant,
we are establishing EIM, via its new device, the mScan®, in conjunction with machine learning cloud-based
platform, as a means of obtaining MRI-like quantitative data in muscle of older adults. With the support of this
administrative supplement, we plan to achieve de novo authorization for marketing from the FDA for the
mScan device and the supporting platform.

Public health relevance
Project Narrative Age-related muscle wasting and weakness, collectively termed sarcopenia, are important contributors to physical limitations in older adults, including impaired gait and mobility. However, there are no convenient tools to quantitatively assess muscle condition in the office. Here we seek to apply the technique of electrical impedance myography (EIM), along with a cloud-based diagnostic engine, as a tool to provide specific measures of muscle health only previously obtainable with MRI or CT, including muscle size, specific force, and fatty infiltration. This technology has the potential to greatly improve the care of older adults and to serve as a valuable, convenient, and cost-effective research tool. This work will result in a device with FDA authorization for marketing which can be used by physicians, nurses, medical technicians and physical therapists.